Core 4

The institutions comprising the NCBO have a long tradition of training tomorrow's investigators. Stanford University has had more than 25 years of continual support from the National Library of Medicine for its training program in biomedical informatics and is widely recognized as providing a model for graduate education in this discipline. The Mayo Clinic, the University at Buffalo, and the University of Victoria all have long and distinguished track records in training students and postdoctoral fellows in disciplines related to our Center's work. The NCBO will collaborate with these existing programs to advance training in biomedical ontology as it applies to practical problems in biomedicine. As a national center, we also seek to improve ontology training across the biomedical research community. Taken together, our Education and Training activities will create an interactive community of graduate students, post-doctoral fellows, visiting scholars, and other scientists who understand the critical role of biomedical ontology and are positioned to communicate that role to the larger biomedical research community.